District of Columbia T32 on Neurodevelopmental Disabilities Research (DC NDD T32)

Project Summary/Abstract
The main objective of our T32 Training Program is to train MD and PhD post-doctoral fellows in research focused
on Neurodevelopmental Disabilities (NDDs). This program, the District of Columbia NDD T32, is associated with
and fully integrated into our District of Columbia Intellectual and Developmental Disabilities Research Center
(DC-IDDRC). The rationale for this program is as follows: 1) Neurodevelopmental disabilities affect a significant
percentage of the US population, and 10% of households live with an individual with an NDD, therefore these
conditions represent a substantial financial and emotional burden in our society; 2) The biological causes of
NDDs range from genetic to acquired insults, requiring an interdisciplinary neuroscience approach to define
underlying causes and mechanisms of disease; and 3) There is significant overlap of symptoms amongst the
various neurodevelopmental disorders, suggesting overlapping mechanisms. Our trainees and mentors use
cutting-edge techniques, including genetic, cellular/molecular, physiological, functional/behavioral, and
structural/dynamic imaging to engage in basic and translational NDD research projects. Multidisciplinary training
is emphasized, based on the variety of training opportunities and core facilities available at the participating
institutions. Children’s National Hospital (CNH) is particularly well positioned to lead this program, based on: 1)
Strengths in basic, translational and clinical research, and in mentorship in all the proposed areas of NDD
research; 2) Substantial institutional resources for research and training in NDDs; 3) Established, strong
collaborations with all participating institutions; and 4) Its leading role in the DC-IDDRC and in many NIH awards
focusing on conditions causing NDDs. Thirty mentors from CNH, George Washington, Howard and Georgetown
Universities will be involved in the program to help develop and support careers of the trainees, including
submission of a K Award application. We request funding for 3 postdoctoral fellows/year who participate in a 3-
year program. The trainees will obtain: 1) specific and integrated training in NDDs and 2) formal and practical
training in basic and essential skills required for independence, with a focus on research methodology, statistics,
and rigor and reproducibility. The training components include a core curriculum consisting of: 1) Subject matter
expertise; 2) Research and quantitative skills, and 3) Communication and writing skills. In addition, trainees will
have customized and experiential components to deepen their training. These include a cross-training rotation
for trainees (e.g., preclinical researchers rotate in the clinic and vice versa); a regular discussion group with a
world-renowned leader and author in the field of NDDs (Mark Batshaw, MD); and we also offer trainees
opportunities to participate in activities that are critical for broadening their perspective on how to conduct
research by interacting with the community they are aiming to help in different venues beyond the lab or clinic,
which will enhance relationships and promote advocacy for the NDD community.

Public health relevance
Narrative It has been estimated that neurodevelopmental disabilities (NDDs) affect at least 10% of all families in the USA. A new generation of multidisciplinary investigators are urgently needed who will be able to apply cutting-edge research approaches and new technology to elucidate mechanisms underlying the pathogenesis and pathophysiology of these disorders, so that new and more effective therapeutic interventions can be developed. The major objective of our NDD training program – the DC NDD T32 Training Program - is to fill this need by leveraging on all resources available at our institutions in the District of Columbia and at our DC-IDDRC. We have been successful in training several generations of investigators in research that will advance our understanding of NDDs, and the proposed program will support training and career development of new investigators by providing 3 years of coaching and experience under the direction of a highly qualified investigator/mentorship team.